Therapeutic interventions for brain-immune interactions during cognitive aging

PROJECT SUMMARY Over the years it has become evident that the immune system can affect the activity of the central nervous system (CNS), including altering cognitive processes. The impact of immune activation on the CNS is particularly important for aged individuals, as the brain's resident immune cells, microglia, acquire a pro- inflammatory profile. Understanding why these cells show increased inflammatory activity (i.e., neuroinflammation) and identifying effective treatments to reduce microglia activation is expected to have beneficial effects on cognitive performance and measures of neural plasticity. The long-term goal of this research program is to identify the physiological underpinnings and functional consequences of increased neuroinflammation in aged subjects and evaluate interventions to delay or prevent these changes. The objective of this application is to identify means of regulating microglia proliferation and assess the contribution of age-related increases in microglia activity to cognitive function. The central hypothesis is that increased microglia proliferation contributes to the heightened neuroinflammation and cognitive decline associated with aging and that increasing physical activity will reduce neuroinflammation. Guided by our preliminary data, this hypothesis will be tested by completion of three specific aims: 1) Identify mechanisms of age-related increases in microglia proliferation. 2) Determine the extent to which increased microglia proliferation in aged subjects contributes to reduced hippocampal neurogenesis, cognitive deficits, and neuroinflammation. 3) Determine whether exercise attenuates proliferation and expression of the proinflammatory phenotype in microglia. The first aim will employ pharmacological manipulations to increase or decrease two endogenous stimulants of microglia proliferation that were found to be increased in aged subjects. Triple-label immunofluorescence will be used to quantify microglia proliferation. In aim 2, spatial learning ability, hippocampal neurogenesis, and neuroinflammation will be evaluated following pharmacological inhibition of microglia proliferation and in P2X7 receptor knockout mice. Our approach for aim 3 is to assess the impact of exercise on the proliferation and activation state of microglia, via flow cytometry and immunofluorescence, in young and aged mice. The present application is innovative, in our opinion, because it focuses on a novel approach to reduce neuroinflammation, namely, through regulating microglia proliferation. Further, it merges the fields of neurobiology and immunology, to understand age-related changes in cognition and neural plasticity. This contribution is significant because it is expected to facilitate development of novel pharmaceutical treatments and explores non-drug based therapies in the form of physical exercise to attenuate chronic neuroinflammation. Ultimately, such knowledge has the potential to facilitate development of efficacious treatments for attenuating neuroinflammation that in the context of aging will help reduce the growing problem of age-related cognitive decline and neuropathologies.

Public health relevance
PROJECT NARRATIVE The proposed research will discover effective ways of reducing inflammation within the aging brain. The outcome is expected to help improve cognitive function and decrease the incidence of neuropathology. The research will have a positive impact by reducing the burden of illness among older adults and by contributing novel treatments to improve longevity and mental health. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Chronic neuroinflammation likely contributes to the susceptibility and/or progression of age-related neuropathologies, such as dementia and Alzheimer's disease. Prior studies have shown that dysregulation of microglial cells, the brain's resident immune cell, underlie the low-grade chronic neuroinflammation that develops with normal aging. However, microglia also promote regeneration after injury. Therefore effective treatments must dampen inflammatory activity while preserving microglia's neuroprotective function. Discovering factors that induce neuroinflammation and investigating potential preventative therapies, such as exercise, is expected to uncover ways of maintaining normal microglia activity in the aged brain. The long-term goal is to identify the physiological underpinnings and functional consequences of increased neuroinflammation in aged subjects and evaluate interventions to delay or prevent these changes. The objective of this application is to identify means of regulating microglia activity and assess the contribution of age-related increases in microglia activity to cognitive function. The central hypothesis is that increased microglia activation contributes to the heightened neuroinflammation and cognitive decline associated with aging and that increasing physical activity will reduce neuroinflammation. The hypothesis is based on our preliminary findings that showed inflammation in the brain of aged mice. Further, we found that exercise reduced markers of inflammation and tended to decrease microglia proliferation. The rationale is to identify means of lowering microglial cell proliferation and activation. This information is important for development of preventative treatments for age-related pathologies through regulating neuroinflammation. This proposal is innovative because it employs a cross-discipline approach, merging the fields of neurobiology and immunology, to understand age-related changes in cognition and neural plasticity. Testing of the central hypothesis will be accomplished through completion of the following specific aims: Aim 1: Identify mechanisms of age-related increases in microglia proliferation. Our working hypothesis is that elevated levels of macrophage-colony stimulating factor (M-CSF) and the purinergic P2X7 receptor increase microglia proliferation in aged mice. Our preliminary data showed that aged mice had increased hippocampal expression of M-CSF and P2X7 receptor, both of which stimulate microglia proliferation. To accomplish this aim, alterations in microglia proliferation will be evaluated in aged mice following pharmacological blockade of the M-CSF and P2X7 receptors. Aim 2: Determine the extent to which increased microglia proliferation in aged subjects contributes to reduced hippocampal neurogenesis, cognitive deficits, and neuroinflammation. Our working hypothesis is that genetic or pharmacological reduction of microglia in aged mice will restore hippocampal neurogenesis and improve behavioral performance. Basal increases in inflammatory molecules can reduce neurogenesis and disrupt cognitive function in aged subjects (Gemma et al., 2007, Weaver et al., 2002). Whether lowering microglia activity is sufficient to attenuate these deficits is unknown. To test our hypothesis, we will use P2X7 receptor knockouts and antagonists against the P2X7 receptor or the M-CSF receptor (alternatively a microglia inhibitor) to reduce microglia proliferation and evaluate neurogenesis, neuroinflammation, and cognition. Aim 3: Determine whether exercise attenuates proliferation and expression of the proinflammatory phenotype in microglia. The working hypothesis is that exercise will be an effective therapy to lower microglia proliferation and inflammatory markers in the aged brain. Our preliminary data suggest that exercise may reduce microglia proliferation in aged mice and decrease markers of neuroinflammation. To test this aim, we will use immunofluorescence to assess microglia proliferation and flow cytometry to measure expression of inflammatory molecules on isolated microglia following exercise training. Completion of this project is anticipated to yield the following expected outcomes. First, completing aims 1 and 2 is expected to identify mediating factors of the age-related increase in microglia proliferation and its effects on neural function. Second, results from aim 3 will determine the utility of exercise as a preventative therapy for age-related changes in neuroinflammation. These results are expected to have an important positive impact, by revealing novel targets and therapies for reducing age-associated neuroinflammation.